HIV and Other Infectious Consequences of Substance Use

PROJECT SUMMARY/ABSTRACT
This is the fourth competitive renewal for T32DA013911 (HIV and Other Infectious Consequences of Substance
Use) and seeks funding for Years 21-25. The program is led by multiple PIs: Dr. Timothy P. Flanigan (the PI
for the past 20 years), who will direct mentoring and training, and Dr. Josiah D. Rich (MPI for the last cycle), who
will direct research project development. This training grant focuses on applied clinical and substance use
research in Rhode Island and beyond. Rhode Island has among the highest rates of substance use in the nation
and ranks 6th in the country for overdose rates. Our substance use training program emerged from the Brown
University-affiliated Miriam Hospital Immunology Center, the largest HIV care center in Southern New England,
where approximately 60% of the patients engage in substance use (alcohol, cocaine, opioid,
methamphetamines, and poly-substance abuse). Our program’s strengths are our interdisciplinary collaborations
to reduce the infectious disease consequences of substance use, including HIV, hepatitis B and C, sexually
transmitted infections, and TB. This training program brings together core expertise from the Division of
Infectious Diseases, the Providence-Boston NIH funded Center for AIDS Research (CFAR), the NIH-funded
COBRE Center on Opioids and Overdose, the Centers for Behavioral and Preventive Medicine, the Brown
University Center for Statistical Studies, and the Brown University School of Public Health. This interdisciplinary
training program focuses on HIV prevention and treatment, including innovative PrEP programs, and correctional
health, with a primary focus on reducing the infectious consequences of substance use as well as overdose. Our
mentors have strong track records in applied clinical, substance use, translational science, correctional health
research, and community-engaged scholarship.

Public health relevance
PROJECT NARRATIVE This program trains post-doctoral fellows in clinical research to more effectively understand and manage the challenges of HIV and other infectious consequences of substance use. Incorporating expertise from multiple disciplines greatly enhances diagnosis, prevention and treatment research of HIV and other infectious diseases among people who use drugs and within communities that are heavily impacted by the substance use and overdose epidemics. Community engagement is emphasized to ensure that marginalized communities benefit from advances in biomedical science.